NIAID / CHILDRENS NATIONAL MEDICAL CENTER JOINT CLINICAL RESEARCH PROGRAM (JCRP) IMMUNOLOGIC AND INFECTIOUS DISEASES CLINICAL RESEARCH

This is a multisite prospective observational study to evaluate the clinical sequelae of symptomatic and asymptomatic severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) infection in the pediatric population (aged 0-21 years), including coronavirus disease 2019 (COVID-19) and multisystem inflammatory syndrome in children (MIS-C).